Time-lapse Flow Cytometry for Kinetic Profiling of T-Cell Function

Abstract
Despite progress in immunotherapies, there are significant challenges to overcome to make them
more broadly applicable to different cancers and more effective for patients. However, current
efforts to improve adoptive cell therapies and immune checkpoint blockade as well as cancer
vaccines are hampered by the lack of a method to characterize the functional and phenotypical
changes of different subpopulations of T cells over time at high throughput. The goal of this SBIR
Phase II project is to develop a novel flow-cytometry method that can solve this technological
bottleneck. The time-lapse flow cytometry uses laser particle (LP) barcodes to track each cell
across flow measurements taken at different time points. Built on demonstrated proof-of-concept
data, this project is focused on establishing a set of novel assays for characterizing T cells in
response to different stimuli in a time-resolved manner. The first specific aim is to demonstrate
short-term time-lapse assays to profile cytokine secretion (t-SEC). Secretion of TNF, IFNγ and
IL10 from millions of the same cells in response to different types of stimulation are measured at
multiple timepoints over 24 hours. The second specific aim is to demonstrate long-term time-lapse
assay to monitor phenotype (t-PHENO), including T-cell exhaustion over 10 days. The third
specific aim is to validate the t-SEC and t-PHENO assays with patient samples. The time-
resolved, high-throughput, high-parameter assays are expected to accelerate the development of
more effective and durable immunotherapies for cancer (>$100 B global market). Beyond
immunotherapy, time-lapse flow cytometry is also expected to be useful in fundamental
immunological research and vaccine development.

Public health relevance
Narrative This project aims to foster fundamental discoveries and innovative research for the improvement of immunotherapies to treat cancer by harnessing the patients’ own immune cells. A major technological limitation is the lack of methods to characterize immune cells over time at high- throughput. The proposed research to develop novel time-lapse flow cytometry addresses this limitation, accelerating immunology and immune-oncology research and development.